URINE TESTING IN POLYCYSTIC OVARY SYNDROME

Classification of patients with PCOS relies on cumbersome laboratory and ultrasound evaluations. This study will examine the role of outpatient urine testing (full alpha subunit and c-peptide) compared with other endocrine abnormalities (detected with frequent blood testing, oral glucose tolerance tests) known to be associated with PCOS. The overall goal is to validate outpatient biochemical tests as a means of defining discrete pathophysiologic subtypes of PCOS patients precisely and accurately.